Leadership Administrative Core

Leadership / Administrative Core (LAC): Project Summary
This Johns Hopkins University (JHU) Older Americans Independence Center (OAIC) Leadership and
Administrative Core (LAC) was designed to provide the scientific leadership, organization and infrastructure
necessary to lead and oversee the frailty-focused activities of this OAIC. The overall goal of the LAC is to
ensure the ongoing success of this OAIC in stimulating and sustaining the next generation of frailty-related
science and the next generation of frailty-focused investigators. The aims of this LAC are to: 1) provide the
interdisciplinary intellectual leadership needed to stimulate and sustain the development of innovative frailty-
focused research, facilitate translation between basic and clinical research on frailty, develop innovative
intervention and prevention strategies from these biological and clinical discoveries, and ensure effective,
high impact utilization of each of the cores of the OAIC; 2) identify and attract the next generation of frailty-
focused research leaders at JHU and facilitate their training, career development and access to resources
to promote their emergence as independent, interdisciplinary investigators in this field; 3) lead, administer,
and oversee core functions to assure productivity, cost effectiveness, integration, and quality of all aspects
of this OAIC program, and well steward OAIC resources; 4) prepare reports or non-competing renewal
applications, annually, and administrative documents as needed, including data safety monitoring
documentation; 5) organize and conduct scientific sessions to propel the frailty-focused science and career
development of participants, including OAIC retreats, research in progress meetings, and research planning
meetings; 6) maximize JHU OAIC scholarly visibility locally and nationally via local programming and
participation in the OAIC network, the annual OAIC scientific meeting, annual scientific meetings of
organizations focused on aging or frailty, and through a new Information Dissemination Core; and 7)
organize independent panels for review of pilot, development project and junior faculty applications and
organize review of progress towards OAIC goals, conducted annually by an External Advisory Board. This
Core will set goals with all other cores and ensure that goals are met. It will lead visioning discussions
among the multidisciplinary Leadership Council as to scientific direction and clinical relevance; provide
institutional leadership in identifying the investigators and mechanisms to accomplish the Center's scientific
goals; and provide leadership and organization to ensure the successful development and implementation
of the infrastructure and new methods needed to support investigators in furthering research on frailty and
its translation to increase the independence of older adults.